Generation of antibodies to monitor Notch O-fucosylation in vivo

Project Summary Notch1 is a cell surface protein that has diverse roles in human biology at all stages of life. Notch1 is modified by a number of sugar structures, including a number that are termed O-fucose. Alteration of the pattern of O- fucose structures found on Notch1 has significant effects on Notch1 function, which in turn has been linked to both developmental and adult pathologies, including cancer. To date the study of O-fucose structures on Notch1 has been severely hindered by a lack of research reagents that can specifically detect and monitor this structure. Currently, mass spectrometry is the method of choice for the analysis of O-fucose glycans on Notch1. Although an extremely powerful technique, it requires specialized instrumentation and expertise not available in most laboratories. Development of sensitive and specific antibodies for O-fucose glycans on Notch1 will provide many investigators with the tools to analyze O-fucose glycans in vivo, including clinical specimens. We will utilize a newly-developed methodology that enables reliable production of antibodies that can recognize distinct protein epitopes in the context of specific glycan modifications to produce antibodies to O- fucose on Notch1. If successful these O-fucose-Notch1-specific antibodies will facilitate research on Notch1 in many laboratories and possibly could lead to new diagnostic and therapeutic tools.

Public health relevance
Project Narrative Modification of the human Notch1 protein by a sugar structure termed O-fucose is now under scrutiny for its role in cell biology and human diseases such as cancer. There are currently no protein-specific reagents to study O-fucose. We propose to develop site-specific O-fucose antibodies to the human Notch1 protein thereby providing valuable tools for the study of O-fucosylation and Notch1 biology and their roles in human disease.